The impact of host hypoxic signaling on antibacterial immunity and bone repair during Staphylococcus aureus osteomyelitis

PROJECT SUMMARY/ABSTRACT
Osteomyelitis is an inflammatory state of bone most commonly triggered by the Gram-positive bacterium
Staphylococcus aureus. Staphylococcal infection of bone is both common and highly morbid. During
osteomyelitis, the structural matrix and vascular architecture of bone is destroyed, resulting in regions of
necrotic, avascular tissue that increase risk of chronic infection. Extreme hypoxia occurs during osteomyelitis
due to an altered vascular supply, inflammatory infiltration, and the metabolism of invasive S. aureus. The host
responds to hypoxia by initiating hypoxia-inducible factor (HIF) signaling. HIF signaling, in turn, modulates
bone remodeling. Beyond bone homeostasis and repair, HIF signaling is implicated in the regulation of
antibacterial immunity. However, the role of hypoxia and HIF signaling during osteomyelitis is unknown
and may serve as an important clinical target for optimizing immune responses to combat invasive
infection. We have developed a powerful murine model of osteomyelitis that recapitulates the pathogenesis of
human disease. Using this model, we demonstrated that extreme hypoxia is present at the infectious focus in a
manner independent of non-infectious fracture healing. Our preliminary data demonstrate that VEGF, a well-
characterized target of HIF signaling, is increased during osteomyelitis relative to mock-infected bone,
consistent with the notion that HIF signaling is activated during invasive infection of bone. Under normoxia, we
also observed that osteoblasts (bone-building cells) sense and respond to S. aureus stimulation in vitro by
increasing the transcription of genes that regulate HIF signaling, control host-mediated bone remodeling, and
mediate innate immune responses. The overarching hypothesis of this proposal is that tissue oxygenation and
host hypoxic signaling responses influence antibacterial immunity and bone repair during S. aureus
osteomyelitis. I will test this hypothesis with two integrated Specific Aims. In Specific Aim 1, I will define the
role of oxygenation in mediating osteoblast innate immune responses and bone homeostasis in response to S.
aureus stimulation in vitro. In Specific Aim 2, I will determine the impact of HIF signaling on antibacterial
immunity and bone remodeling during S. aureus osteomyelitis. Within the experiments of Aim 2, I will use in
vivo analyses that will harness both mouse genetics and biomaterial science to alter HIF signaling during
osteomyelitis and investigate the impact of HIF on immune responses and bone repair. Together these studies
will 1) define the role of oxygenation in dictating the innate immune and bone remodeling responses of
osteoblasts, 2) define the impact of osteoblast HIF signaling on antibacterial immunity and bone repair during
S. aureus osteomyelitis, and 3) test the potential of HIF-targeted therapies as an anti-infective adjuvant for
invasive infection of bone. Collectively, this proposal will elucidate how oxygenation impacts skeletal cell
biology and the innate immune responses to bacterial pathogens while providing ideal training and mentorship
to develop my future career as an independent investigator and physician-scientist.

Public health relevance
PROJECT NARRATIVE Osteomyelitis, an inflammatory disease of bone most commonly caused by Staphylococcus aureus, destroys the integrity of bone and requires long courses of antibiotics to treat. During osteomyelitis, destruction of the blood supply to the bone and high metabolic demands of the host and pathogen cause profound hypoxia. The main objective of this research proposal is to determine how hypoxia impacts antibacterial immunity and bone healing during osteomyelitis.